Pathology

ABSTRACT
The Pathology Core is an integral pillar of the MSK Precision Pathology Biobanking Center and provides
a comprehensive resource for human tissue-based research that takes advantage of the unique tissue
resources available at MSK. The acquisition and banking of human biologic specimens to be used to
study causes, detection, prevention, and treatment of cancer have become an indispensible resource
for basic and translational cancer researchers throughout MSK. The reliability of molecular data
derived from new technology platforms depends on access to an adequate supply of optimally
procured, high-quality tissue specimens. The Pathology Core at MSK provides efficient and cost-effective
services to facilitate tissue use and to conduct human biospecimen-based experimentation. The Core also
serves as a national resource, as evidenced by the over 1,000 samples from multiple tumor types that have
been provided to the NCI-funded TCGA initiative, as well as the samples that will be contributed to
the NCI’s CPTAC proteogenomics consortium.
The Histology Service within the Core facilitates selection of appropriate specimens for tissue analyses
and provides the basic services of cutting, dissecting, and staining of fresh-frozen and formalin-fixed,
paraffin-embedded tissues. It includes construction of tissue microarray blocks and laser capture
microdissection for isolation of pure cell populations and tumor cell enrichment. The Core’s
Immunohistochemistry Service provides automated and manual staining using optimized monoclonal and
polyclonal antibodies to be used in clinico-pathologic research studies. The service also continuously
develops and optimizes protocols for new antibodies and for a variety of sensitive detection systems.